Regulation of bone homeostasis and remodeling by long noncoding RNA Malat1

Regulation of bone homeostasis and remodeling by long noncoding RNA Malat1
Bone homeostasis is maintained by constant and dynamic remodeling between osteoclast-mediated bone
resorption and osteoblast/osteocyte-mediated bone formation. The balance of bone remodeling process,
however, is often disrupted in pathological conditions, such as in osteoporosis and rheumatoid arthritis.
The mechanisms that regulate bone remodeling are not fully understood. Recent genomic studies have
unveiled functional long noncoding RNAs (lncRNAs), and targeting lncRNAs provided exciting new
diagnostic and therapeutic opportunities for human diseases. The lncRNAs involved in bone remodeling,
however, are underappreciated. Malat1 is one of the most conserved and abundant nuclear lncRNAs. The
function of Malat1 is unknown in bone homeostasis and remodeling. We revealed, for the first time, that
Malat1 KO mice exhibit significant osteoporotic bone phenotype characterized with enhanced osteoclastic
bone resorption, but reduced osteoblastic bone formation in vivo. Thus, Malat1 deletion uncoupled the
normal bone remodeling between osteoblasts and osteoclasts. Malat1 acts cell-autonomously in
osteoblasts to promote osteoblast differentiation, but suppresses osteoclastogenesis in a non-autonomous
manner in vivo. Moreover, Malat1 modulates crosstalk between osteoblasts and osteoclasts.
Mechanistically, Malat1 deficiency significantly reduced nuclear localization of β-catenin during
osteoblastogenesis. The genes enriched in pathways of osteoblast signaling, ossification, and Wnt/β-
catenin pathway were selectively and significantly suppressed in Malat1 KO osteoblasts. These findings
identify lncRNA Malat1 as a novel bone remodeling regulator that impacts skeletal homeostasis by
controlling both bone formation and resorption.
In this application, we will apply robust genetic approaches to investigate the functional importance
of Malat1 in osteoblast lineage and the mechanisms by which Malat1 regulates osteogenesis and
osteoblast-osteoclast crosstalk. Specifically, we will 1) dissect and define the function of Malat1 in
osteoblast lineage at various stages of differentiation in vivo using genetic approaches; 2) investigate the
mechanisms by which Malat1 regulates osteogenesis and osteoblast-osteoclast crosstalk. Successful
completion of the proposed studies will introduce functional lncRNAs into bone field, yield novel insights
into lncRNA-mediated mechanisms that regulate bone homeostasis and remodeling, and will provide a
rational framework for developing lncRNA-based new or alternative therapeutic approaches for skeletal
diseases.

Public health relevance
Project Narrative Bone destruction is a severe consequence of many skeletal diseases, such as osteoporosis and rheumatoid arthritis. This application will explore underlying mechanisms and provide new attractive therapeutic approaches for suppressing bone destruction and preventing disease development and progress.